The Mount Sinai Transdisciplinary Center on Early Environmental Exposures

Project Summary
Our “Transdisciplinary Center on Early Environmental Exposures” has catalyzed remarkable environmental
health research growth in just 3 years. We have formed new transdisciplinary teams, linked together scientists
with dissimilar backgrounds to address complex research questions, and built a strong base of NIEHS funding
including a CHEAR lab hub, the CHEAR Data Center, 2 ECHO grants, 5 new R01s, and 9 K awards themed
on environmental health. Our Pilot Projects have fueled much of this growth and have been a strong vehicle for
career development. Our Research Groups emphasize early life chemical and physical environmental
exposures, their mixed exposure effects, their interactions with the social environment as well as the role of
sexually dimorphic responses to exposure. Through our community partnerships, we translate our research
findings into evidence-based approaches for disease prevention and treatment with strong links to community
groups and physicians. Our Center supports three Facility Cores: an Integrated Health Sciences Facility Core
that supports biomarker research and access to research populations (both clinic patients and NIH funded
longitudinal cohorts), a Biostatistics and Bioinformatics Facility Core that supports analysis of environmental
health/toxicology data and creates new data analytical methods for complex mixtures; and a clinically-oriented
Phenotyping and Environmental Modifiers Facility Core that supports state of the art health measures as well
as measures of the environmental modifiers (stress, nutrition etc). Our Community Engagement Core is
committed to bidirectional communication and partnership with the diverse and disadvantaged communities
that Mount Sinai serves. Our NIEHS Core Center supports the infrastructure that our research teams depend
upon and will continue to build capacity for new research programs in environmental health. In fact, we are
now poised to expand, given our newly announced “Institute for Exposomic Research” (see Dean's letter). This
new institute will provide infrastructure and staffing resources to further increase capacity of our facility cores
and stay abreast of the many scientific breakthroughs that will undoubtedly occur in Exposure Science and
Environmental Health. The institute is built around our P30 Center which is its center of operations. Finally, our
program is clearly in line with NIEHS strategic goals. Our Research groups (multiple exposures/mixtures,
stress-chemical interactions and sex specific effects) are designed to address the NIEHS strategic plan which
emphasizes the study of multiple exposures working via multiple mechanisms. NIEHS's strategic plan
emphasizes understanding shared biological pathways of exposures, understanding individual susceptibility,
studying mixtures/exposomics, environmental causes of disease, health disparities and community
engagement, all of which are inherent in our Center's work. In closing, our P30 Center has been remarkably
successful in its very first grant cycle, is about to grow even further, and in this renewal will continue to meet
the changing infrastructure needs of our environmental research community.

Public health relevance
Project Narrative The Mount Sinai Transdisciplinary Center on Early Environmental Exposures (1) supports state-of-the-art research infrastructure to discover the environmental causes of disease and disability across the lifespan, (2) translates scientific discoveries into new, evidence-based strategies for disease prevention and treatment, and (3) builds the careers of young physicians and scientists dedicated to environmental health research.